Project 4: MPN-RC Clinical Consortium

Abstract
The myeloproliferative neoplasms (MPNs) are chronic hematological malignancies originating at the level of
the pluripotent hematopoietic stem cell (HSC). This unique assembly of both laboratory and clinical MPN
investigators coupled with the infrastructure to conduct independent, investigator-initiated, multicenter, trials
has proven to be rewarding over the last 10 years of continuous NCI-funding and is poised to continue to
further evolve. Keeping in mind the constructive reviewer comments, we have concentrated our clinical efforts
into a stronger and more nimble consortium of 9 core clinical sites based solely in North America with
established centers of excellence in MPN. The new application for Project 4 (formerly Project 6) is focused on
myelofibrosis (MF) the MPN with the most limited survival and the clinical translation of mechanism based
therapeutics derived from disease targets identified in Projects 1-3. An initial wave of early phase, single agent
clinical trials (MPN-RC 116-118) will be conducted in years 1-3 and then three innovative combination therapy
trials derived from supportive pre-clinical data and single agent tolerability and signal of activity will be pursued
in years 3-5 (MPN-RC 119-123). Additionally, primary MPN tissue will be acquired through the MPN-RC tissue
procurement protocol (Core B) and genomically characterized (Core D) from patients seen at all sites for
distribution to Projects 1-3. Each trial will also have study schedule-specific, protocol driven, biomarkers to
determine 1) effect on MPN HSC burden through mutational and cytogenetic analysis; 2) confirmation of
proposed therapeutic mechanism of action through drug specific pharmacodynamic studies; 3) restoration of
normal bone marrow microenvironment through histomorphologic analysis and cytokine expression profiles.
The overarching goal of Project 4 is to test agents and innovative approaches that alone or in combination
delete the MF HSC and favorably modify the MF-supporting microenvironment, thereby, altering the natural
history of MF and improving patient outcome. The specific aims include 1) Annually obtain peripheral blood
from MF patients in order to provide molecularly characterized tissue specimens that will be utilized for the
investigations planned in Projects 1-3; 2) Conduct early phase clinical trials years 1-3 utilizing agents targeting
the MPN HSC that have mechanistic rationales originating from Projects 1-3; 3) Evaluate therapeutic agents in
early phase clinical trials years 1-3 that can interrupt the MF HSC supporting tumor microenvironments and,
thereby, restore a bone marrow niche favoring normal hematopoiesis; 4) Utilize agents from Phase I/II trials
associated with Aims 2 and 3 that can be tested in combination therapy approaches in years 3-5. The close
interaction among the scientific projects, biostatistical, administrative, tissue bank, and biomarker cores with
Project 4 embodies the true potential for translational research in MF that only the MPN-RC can provide.

Public health relevance
The overall goal of this project is to directly translate therapies originating from therapeutic targets identified from scientific Projects 1-3 into novel treatment strategies targeting the myeloproliferative neoplasm (MPN) hematopoietic stem cell (HSC) and the supportive microenvironmental abnormalities in patients with myelofibrosis (MF). Such therapies will be evaluated in investigator-initiated, early developmental phase, clinical trials with agents derived from the scientific Projects (1-3) and designed to deplete the MPN HSC through direct anti- clonal activity and modification of the impaired microenvironment, thereby favorably altering the natural history of disease.